Tau Metabolism in FTD: From Gene Mutations to Molecular Chaperones and Lysosomal Proteases

PROJECT SUMMARY
Pathological tau deposition occurs in a subset of neurodegenerative disorders including frontotemporal
lobar degeneration with tau inclusions (FTLD-tau). Much of what is known about FTLD-tau is derived
from mutant tau models or overexpression. However, a unified view of overall tau metabolism—from its
initial production, interactions with molecular chaperones, post-translational modifications, targeting to
lysosomes/autophagy, and resultant degradation, to our knowledge has not been generated The long-
term goal of this proposed FTD Center without Walls (CWOW) is to improve our understanding of the
pathobiological mechanisms underlying FTD-tau. Its overall objective is to elucidate the genes,
molecules and pathways that regulate tau metabolism and to determine the impact of disease-
associated mutations and variants. Our central hypothesis is that proper tau metabolism requires the
precise, coordinated action of molecular chaperones, co-chaperones, PTMs and degradation
machinery that each represent regulatory nodes. Genetic mutations in tau and other pathway members
can disrupt tau metabolism, leading to tau accumulation, secretion and neurodegeneration. The Center
will be led by Dr. Aimee Kao, who will also lead Core A: Administration and Data Core (with Co-lead Dr.
Yokoyama) and Project 1: Tau Molecular Chaperones, targeting and proteolysis (with Co-I Dr. Agard).
Dr. David Agard will oversee Core B: Macromolecular and Cellular Structure Core. Dr. Jennifer
Yokoyama will lead Core C: Genomics and Transcriptomics. Finally, Dr. Celeste Karch will lead Project
2: Tau Half Life and Secretion. We will achieve these objectives through four Specific Aims. Aim 1:
Understand the normal process of tau metabolism as a series of decisions that are made at regulatory
nodes. Aim 2: Identify and test the functional relevance of genetic variants in MAPT and other tau
metabolism genes, in in vitro, cell and iNeuron models, on each of the tau metabolism regulatory
nodes. Aim 3: Integrate findings from Projects and Cores to produce a Tau Metabolism and Variant
Database (TMVdb), that will serve as a reference point for the field. Aim 4: Integrate findings from
Projects and Cores to produce a Tau Polygenic Risk Score (TPRS), which will stratify genetic risk for
tauopathy. Upon successful completion of these Aims, the proposed FTD CWOW will have provided
fundamental information about tau metabolism, defined mechanistic nodes predisposing to tauopathy
and generated the TMVdb and TPRS, new resources for the fields of tauopathy and neurodegeneration
research. It will generate critically important information about tau homeostasis and a foundational
basis from which to build and frame subsequent investigations into tau pathobiology and toxicity.

Public health relevance
STATEMENT OF PUBLIC HEALTH RELEVANCE The proposed research is relevant to public health because, as our population ages, the financial and societal burden of neurodegenerative diseases will greatly expand over the coming decades. This proposal seeks to generate knowledge and resources around a broad-based understanding of tau metabolism. The proposed research is relevant to the NIH's mission of extending healthy life and reducing the burdens of illnesses like neurodegeneration, since its findings will enhance related efforts to target tau clearance and develop therapies for neurodegenerative diseases such as FTD.